Trapping reactive intermediates and their application towards catalysis

Project Summary
The family of monooxygenase enzymes are utilized to perform oxidative group transfer catalysis to broadly drive
one of two functions: (1) metabolize hydrocarbon building blocks (e.g., steroids, fatty acids) for waste
management or hormone synthesis in cytrochrome P450 (CYPs); and (2) the utilization of methane as the sole
carbon and energy source (i.e., methanotrophic bacteria). The common trait amongst the oxidizing enzymes is
the ability to electronically tune their catalytic centers to achieve oxygen transfer to robust C–H bond substrates.
Adapting the electronic structure tuning principles to devise new synthetic, abiological catalysts holds great
promise to (1) understand how the enzymatic systems might function by uncovering what reaction sequences
are possible, and (2) developing new catalytic reactions that mimic the reactivity of the monooxygenases.
This proposal describes the synthesis and characterization of novel metal-ligand multiple-bonds and
metal-stabilized radicals to mimic the function of biological monooxygenases. Monooxygenases utilize metal-
oxenoid ligands to drive C−H bond activation and C−heteroatom bond formation, providing a blueprint on how to
emulate this reactivity. The ability to selectively incorporate functionality into unactivated C–H bonds represents
a significant advance in converting inexpensive chemical feed stocks (e.g. hydrocarbons) to value-added
functional molecules (e.g., pharmaceutical precursors). To achieve this goal, this proposal outlines a strategy to
generate metal-ligand multiply-bonded complexes featuring oxenoid functionalities and examine their reaction
chemistry as a function of transition metal and oxenoid ligand redox state. This proposal seeks to address the
following questions: (1) Which transition metal-oxo linkage and attendant electronic structure can facilitate C-H
bond hydroxylation chemistry? (2) Can monomeric copper support a terminal oxo-like ligand as would be
suggested for the reactive oxidant in particulate methane monooxygenases? (4) How do functional group
oxidation states (i.e., oxo, oxyl, oxene) impact functional group transfer catalysis? (5) Can metal-stabilized ligand
radicals in general be developed to enable new C-H bond functionalization catalysis?
Using dipyrrin ligand platforms as truncated models of the porphyrin platform found in cytochrome
monooxygenases, this proposal outlines a strategy to synthesize and characterize metal-ligand multiple bonds
on iron, cobalt, nickel, and copper. A sterically encumbered dipyrrin is proposed to be ideal for the synthesis,
crystallization, and full spectroscopic characterization of a terminal oxenoid adducts of Cu akin to the potential
terminal Cu(O) adduct in particulate methane monooxygenase. The broader scientific impact of the proposed
research can be summarized as the following: this study will improve the field’s understanding of factors
contributing to the promotion of productive C–H bond activation and functionalization, further developing new
catalysts to synthesize value-added, commodity chemicals via clean reaction routes with minimal waste product.

Public health relevance
Project Narrative The ability to selectively incorporate heteroatom functionality into unactivated C–H bonds represents a significant advance in chemical synthesis. Developing functional mimics of the monooxygenase reactive intermediates will permit the generation of a new class of catalysts to effect C−H bond functionalization. Correlating the desirable functionality to the underlying electronic structure of reactive intermediates will provide new strategies for catalyst development.